Remodeling of inter-organelle communication during Chlamydia infection

SUMMARY
Chlamydia trachomatis is the leading cause of sexually transmitted infections of bacterial origin. No vaccine is
available. Infections are often asymptomatic, leading to long-term damage of the reproductive organs and
deleterious effects on women reproductive health ranging from pelvic inflammatory disease to infertility. For
successful infection, Chlamydia actively modulates the function of nearly all host organelles. However, the
molecular mechanisms involved are poorly understood and all studies performed to date have focused on host
organelles in isolation. Here, we aim to consider that modulation of inter-organelle communication may be the
mechanism by which Chlamydia rewire organelles function to create an intracellular niche favorable for
intracellular replication. To this aim, our strong team of collaborators will provide the first initial holistic view of
inter-organelle communication during Chlamydia infection, by using novel and state of the art techniques and
approaches. Altogether, we will determine which, when, and how organelle-organelle interactions are modulated
by Chlamydia, and reveal how perturbation impacts function. Our studies have the potential to identify novel
targets to combat Chlamydia infection and to make a mark on the field of inter-organelle communication in the
context of host-pathogen interactions.

Public health relevance
PROJECT NARRATIVE Chlamydia trachomatis is the leading cause of sexually transmitted infection of bacterial origin in the US. Infec- tions are often asymptomatic and, if left untreated, can lead to permanent damage of women’s reproductive organs. Our goal is to elucidate how the bacterium manipulates cellular organelles and pathways to establish its replication niche and induce pathogenesis.